Analytical Lab

The mission of the Analytical Laboratory for Pharmacogenetics, Pharmacodynamics and Pharmacokinetics (3P) is to advance clinical cancer research by providing accurate and efficient state of the art data and analyses of pharmacogenetics, pharmacodynamics and pharmacokinetics parameters. The 3P Laboratory has three services available to Cancer Center members, instrumentation, analytical service and the sample acquisition service. 1. Instrumentation The 3P Laboratory maintains and instructs Cancer Center members on the use of all laboratory equipment housed in the 3P Laboratory. The 3P Laboratory has 1,200 square feet of laboratory space and 240 square feet of office space which house over 25 laboratory instruments. The space was specially designed for efficient use and maintenance of analytical instruments. The laboratory design also facilitates timely and efficient processing of clinical samples. 2. Analytical Services The 3P Laboratory is designed as a facility for developing and executing a wide variety of bioanalytical methods, including processing and analyzing samples for PK/PD/PG studies in support of Phase I, II, III and chemoprevention clinical trials. This service includes development and performance of original assays for new agents, assays to monitor endogenous biochemicals, genotyping and mutation assays and adaptation of existing methodology for analyses where applicable. 3. Sample Acquisition Services (SAS) The 3P Laboratory also offers a Sample Acquisition Service for all UWCCC clinical trials. This service is offered to all investigators participating in clinical trials requiring acquisition, processing, storage and shipping of samples for PK/PD/PG studies.